The Role of SMARCAL1 Depletion on Increased Immunogenicity in ALT+ Gliomas

PROJECT SUMMARY/ABSTRACT.
Approximately 10 to 15% of all cancers utilize the alternative lengthening of telomeres (ALT) mechanism to
maintain telomere length and achieve replicative immortality. ALT occurs frequently in high-grade gliomas
(HGGs), including IDH-mutant astrocytomas, pediatric HGGs with H3G34R mutations, and a subset of adult
primary GBMs. The overarching goal of this F32 Fellowship Award is to investigate the role of SMARCAL1, an
annealing helicase that catalyzes replication fork reversal, in promoting glioma cell proliferation and
suppressing tumor-intrinsic inflammation. HGGs are notoriously immunologically cold with large suppressive
myeloid compartments. Current therapies have struggled to generate an immune response. Our preliminary
data in pre-clinical glioma models shows that therapeutic targeting of SMARCAL1 represents a path to tumor-
cell specific DNA damage and inflammation, and depletion of SMARCAL1 increases replication stress, DNA
damage, and aberrant DNA and RNA species. This project will investigate the intrinsic and extrinsic
inflammatory response following SMARCAL1 depletion in ALT+ HGG cell lines and orthotopic syngeneic
murine glioma models. SMARCAL1 will be depleted in human ALT+ HGGs and syngeneic murine ALT+ cell
lines utilizing RNAi lentiviral particles containing two distinct doxycycline-inducible SMARCAL1-targeting
shRNAs. In vitro studies will involve investigation of pattern recognition receptor (PRR) signaling within tumor
cells and the resulting effects on the secretome, measured using western blot and LegendPlex. The specific
mechanism of PRR derived inflammation will be elucidated using CRISPR/Cas9 gRNA knockdown studies
and visualized using IF-FISH with confocal microscopy. The effect of inflammation on phagocytic myeloid cells
will be monitored using living cell imaging and flow cytometry. In vivo studies will investigate the inflammatory
response in orthotopic murine glioma models in C57Bl/6 mice with syngeneic tumors. These studies will
identify alterations to the inflammatory profile of ALT+ tumors within tissue context and provide information on
the role of the immune system following SMARCAL1 depletion using both in vivo and ex vivo models.
Alterations in the inflammatory response and T cell mediated cytotoxic killing will be investigated using flow
cytometry and transcriptomics. Both mentors are experts in the field with well-respected publication records in
the fields of HGG, ALT, and SMARCAL1 and will provide the appropriate mentorship as Dr.
Erman transitions her immunology expertise from nephrology to oncology, as well as facilitating her mentorship
of more junior members. The resources and facilities at Duke University are exemplary and all studies will be
performed using the most modern techniques with the guidance of experienced and respected collaborators.
The proposed studies include techniques Dr. Erman has extensive experience with including flow cytometry
and transcriptomics yet allowing her to apply them to a new field, and areas for growth including murine glioma
models, cell culture, and IF-FISH with confocal microscopy.

Public health relevance
PROJECT NARRATIVE. SMARCAL1 is a novel tumor specific therapeutic target for high grade gliomas (HGGs) that utilize alternative lengthening of telomeres (ALT). We will investigate the effects of targeting SMARCAL1 on inflammation within tumor cells and the ability of immune cells to recognize and respond. These studies will provide novel insight into the mechanisms governing tumor-intrinsic inflammatory signaling and how they can be targeted for glioma immunotherapy.